LURN II: Enhanced Characterization of Patients with LUTS Using Biopsychosocial Approaches

ABSTRACT
This application is in response to PA-20-272: Administrative Supplements to Existing NIH Grants and
Cooperative Agreements (Parent Admin Supp Clinical Trial Optional). Summary of parent-award
Specific Aims. The Symptoms of Lower Urinary Tract Dysfunction Research Network (LURN) was
assembled in 2012 to increase the understanding of lower urinary tract symptoms (LUTS). Related to this
goal was the improvement of patient-centered assessment of LUTS. This work involves improving the
self-report measurement of LUTS using new, high-quality items to be used in questionnaire assessments.
These items were created with qualitative input from patients, community participants, internists,
urologists, urogynecologists, and clinical researchers. This set of items is referred to as the
Comprehensive Assessment of Self-Reported Urinary Symptoms (CASUS). The original aims of the
grant were Aim 1: To refine and expand a clinically-relevant cluster model across a cohort of patients
with LUTS. Relative to LURN I, participants will have a wider range of symptom severity and be
characterized using novel measures of bladder and urethral function; Aim 2: To identify protein
biomarker signatures contained within plasma of specific subgroups of men and women with LUTS;
Aim 3: To determine phenotypic characteristics of women with LUTS by measuring the functional
components of the lower urinary tract; Aim 4 To validate comprehensive outcome tools for men and
women with LUTS; and Aim 5: To determine influences of stress and mental health on LUTS. In this
supplement, we will focus on an orderly closeout of the project, which includes completion of
manuscripts as well as curation of data consistent with open science.

Public health relevance
PROJECT NARRATIVE The Symptoms of Lower Urinary Tract Dysfunction Research Network (LURN) was assembled in 2012 to increase the understanding of lower urinary tract symptoms (LUTS), including the determination of relationships between psychosocial variables and LUTS. In this supplement, we will focus on an orderly closeout of the LURN – a research network that has been in place for more than a decade. As part of the closeout of this project, our multidisciplinary team will contribute to the completion of manuscripts focused on cognitive function, symptom trajectories, psychosocial variables, and psychometric properties created by the LURN (the LURN Symptom Indices).